SAFETY, EFFICACY OF RD HEPARIN FOR PREVENTION OF RESTENOSIS AFTER PTCA

A randomized multicenter double-blind placebo controlled drug study to determine if new preparations of low molecular weight heparin show less interference with platelet function and decreased overall clotting activity.